Imaging of Neurovascular Response for Assessment of Alzheimer's Disease

ABSTRACT
Alzheimer’s disease (AD) is the most common cause of dementia and currently the seventh leading cause of
deaths in the United States. In the absence of any therapeutics that can undo neurological damage associated
with AD, it is well established that early detection of AD can lead to improved outcomes for the patient, the care
provider, and the payor. Our project seeks to pursue a bold avenue for an early-stage biomarker for AD by
enabling rapid, noninvasive assessment of cerebrovascular dysfunction, which is known to be impaired in AD.
Because assessment of localized neurovascular reactivity (NVR) in the brain is difficult to accomplish
noninvasively, we seek to estimate it using observations in the retina and retinal vasculature which are known to
share structural and functional similarities with the brain. During Phase I, we will demonstrate proof of concept
in animal models. Our proposed solution – VasoVUE NV – will stimulate the mouse retina with flicker illumination
and use laser speckle contrast imaging (LSCI) to monitor concomitant blood flow changes. Observations will be
compared with whisker stimulation derived changes in blood flow over the whisker barrel cortex monitored using
LSCI and multiphoton microscopy. Once validated, stimulus-evoked blood flow response will be obtained from
the retinae and cortical regions of transgenic mice demonstrating amyloid pathology and compared with controls
to assess the feasibility of detecting NVR impairment. In doing so, we will develop an in vivo imaging platform
(VasoVUE Lab) that can be marketed to academic researchers for simultaneous, synchronous stimulation and
imaging of the eye and brain and find broad use in oculomics investigations on AD and other neurodegenerative
diseases. If our Phase I project is successful, we expect to develop a clinical-grade instrument for retina-based
NVR assessment and conduct clinical validation during Phase II studies.

Public health relevance
RELEVANCE TO PUBLIC HEALTH This project proposes to develop advanced imaging tools that can initially assist academic researchers investigating the pathophysiology of Alzheimer’s disease and other neurodegenerative diseases, and eventually assist clinical management of these debilitating conditions through early diagnosis and important insights.